Regulation of Lipid Droplet Biogenesis and Lipophagy

Project Abstract
Project Abstract is included in the Scientific Justification section of this application.

Public health relevance
Project Narrative – from original application Lipid Droplets are specialized transient organelles that serve as reservoirs of neutral lipids that can be tapped for energy or to resupply membranes with lipids. Failure to store or use lipids efficiently is the hallmark of metabolic diseases. The proposed research will elucidate the molecular mechanisms that lipid droplet proteins use to regulate lipid metabolism, as well as how alterations in these processes impact cellular energy homeostasis. Ultimately, understanding the molecular control of lipid storage and catabolism will be paramount to gain new insights into lipid storage diseases that will form a considerable healthcare burden in the near future.